Interactions Between Diverse Brain Cell Types Drive Aicardi-Goutieres Neuropathology

ABSTRACT
Aicardi Goutières (AGS) is a severe autoinflammatory disease that predominantly affects the brain, leading to
severe cognitive and physical disabilities. Although this disease is genetically heterogeneous, all genotypes
lead to multi-system excessive type 1 interferon (IFN) activity. How the systemic inflammatory response in AGS
leads to predominant central nervous system (CNS) injury is not entirely understood, which limits development
of effective and targeted therapies for this destructive disease. In this study proposal, we aim to uncover the
“driver” cell in either the peripheral or CNS immune system or at brain vascular interfaces that converts genetic
mutations into progressive, IFN-mediated neuronal and oligodendrocyte injury. Using the first rodent models
with AGS patient mutations that confer neuropathology, paired with new viral targeting approaches and
immune chimeric models, we will test which cell(s) promote(s) neuropathology. We will use these approaches
to further interrogate which compartment requires rescue for AGS treatment. This proposal leverages the
unique expertise of three separate laboratories at the University of Pittsburgh (Wang) and Children’s Hospital
of Philadelphia (Bennett and Vanderver) to dissect, for the first time, the distinct populations of cells driving
AGS neuropathology and treatment.

Public health relevance
NARRATIVE Aicardi Goutières syndrome (AGS) is a progressive, autoinflammatory encephalopathy caused by genetic mutations in nucleic acid sensing and processing machinery that leads to overproduction of type I interferon. How systemic IFN production leads to predominant neuropathology is unknown but is imperative to understand for therapy development. This proposal uses mouse models of AGS that recapitulate neuropathology, paired with new gene and cell targeting approaches to uncover the cells, which drive pathology in order to facilitate therapy development.